Race/ethnic Differences Among Older Patients with Type 2 Diabetes at Risk for Hypoglycemia

This research is proposed under PA-20-222: Research Supplements to Promote Diversity in Health-Related
Research as an Administrative Supplement to R01 DK134446: “Pragmatic Clinical Trial of Continuous Glucose
Monitoring-based Interventions for Safe Insulin Prescribing in High-Risk Older Patients with Type 2 Diabetes,
02/01/2023 - 01/31/2028 (R. Grant PI).” Jose Mejia, BA, is the underrepresented minority researcher who will
join the study team and who wishes to obtain mentored research experience in preparation for applying for
admission to graduate nursing school. His career goal – based in part on his own and his family’s lived
experience interacting with the US health care system - is to pursue a career as a researcher within the
field of nursing with a focus on the care of Latino patients with diabetes. The planned mentored research
analyses will supplement the parent R01 by allowing an increased emphasis on examining the similarities and
unique differences in how older Latino patients with diabetes engage with the health care system and to
current medication-related practices. Further study focused on older Latino in our trial has the potential to
provide useful insight into how to best engage this patient population in research designed to improve
engagement and reduce medication risk. Dr. Grant will serve as primary research and career mentor. He is a
former recipient of a 5-year K24 Mid-Career Mentoring award (DK109114: Mentored Research to Improve
Care for Complex Patients with Diabetes). He has a robust track record of serving as a research and career
mentor to early-stage investigators. In the past 10 years, Dr. Grant has successfully mentored six under-
represented post-baccalaureate scholars through this same URM mechanism. The planned mentoring and
research training activities are designed to help Mr. Mejia gain new research skills and improve his potential for
successful enrollment in nursing school. His overarching career goal is to pursue advanced training to gain
necessary clinical and further research skills to become a leader in the field of Latino patient-centered
research. His proposed Administrative Supplement project will be a critical first step towards this career goal.
We have designed a plan that will give him the opportunity to learn quantitative skills (hypothesis, defining
exposures and outcomes, univariate and multivariate analysis techniques) and qualitative skills (drafting an
interview guide, focus group, thematic analysis within a conceptual framework). Given the ongoing health
disparities experience by older Latino patients with type 2 diabetes, there is a continuing need both within our
own institution and nationally for new researchers with strong culturally relevant backgrounds and personal
drive and interest in addressing the problems faced by these patients when interacting with the health care
system.

Public health relevance
This Administrative Supplement to Promote Diversity in Health-Related Research will support the career development of Jose Mejia, a post-baccalaureate scholar who will receive a mentored research experience in preparation for applying for admission to nursing school. Under the guidance of Dr. Grant (PI for R01 DK134446: “Pragmatic Clinical Trial of Continuous Glucose Monitoring-based Interventions for Safe Insulin Prescribing in High-Risk Older Patients with Type 2 Diabetes, 02/01/2023 - 01/31/2028), Mr. Mejia will gain research experience by analyzing baseline data related to older Latino participants with type 2 diabetes eligible for the parent clinical trial (approximately 12% of expected participants, similar proportion to the source population in Northern California). The planned projects will supplement the parent R01 by allowing an increased emphasis on examining the similarities and unique differences in how older Latino patients with diabetes engage with the health care system and to current medication-related practices.